Tet-mediated DNA hydroxylation vs formylation and carboxylation in NSC biology

ABSTRACT
The Ten-Eleven Translocation (Tet1/2/3) family of enzymes promote DNA demethylation and are highly
expressed in neural stem cells (NSCs). They catalyze the stepwise oxidization of 5-methylcytosine (5mC) to 5-
hydroxymethylcytosine (5hmC), 5-formylcytosine (5fC), and 5-carboxylcytosine (5caC). These modified
cytosines are removed by thymine DNA glycosylases (TDG) to promote active demethylation. They also interfere
with recruitment of Dnmt1 during replication thereby promoting passive DNA demethylation. 5hmC is stable and
abundant in various cell types, particularly in the nervous system, which suggests that not all DNA hydroxylation
leads to demethylation. By uncoupling Tet-mediated DNA hydroxylation from formylation and carboxylation, we
may elucidate novel functions of these enzymatic processes in the epigenetic regulation of gene expression in
NSC biology. We hypothesize that Tet-mediated DNA hydroxylation vs. formylation/ carboxylation contribute
uniquely to gene regulation and biology in NSCs. To dissect these dual catalytic functions, we have introduced
a mutation in all three Tet genes in ESCs that abrogates Tet’s ability to formylate and carboxylate, which we call
Tet1/2/3 Formylation/Carboxylation (FoCa) mutant (Tet-FoCam/m) ESCs. This line can generate 5hmC but not
5fC and 5caC in contrast to our Tet1/2/3 full catalytic mutant ESCs (Tet-Catm/m) ESCs that lack all oxidative
activities. We will differentiate these lines to NSCs to: (1) establish the biological requirements of Tet-mediated
DNA hydroxylation vs formylation/carboxylation in the self-renewal and multipotency of NSCs, and (2) define
how Tet-mediated DNA hydroxylation vs formylation/carboxylation regulate neural genes critical for NSC biology.
Findings from these studies will establish the individual contributions of Tet-mediated DNA hydroxylation vs
formylation/carboxylation and uncover the significance of 5hmC, 5fC, and 5caC in NSC gene regulation and
biology. Under the joint mentorship of Drs. Meelad Dawlaty and Bernice Morrow, I will successfully complete the
proposed research and training plan. This research program will enhance my knowledge of stem cell biology
and facilitate my scientific and professional development by equipping me with the necessary skills to become a
physician-scientist.

Public health relevance
Project Narrative Tet enzymes are epigenetic modifiers. They are highly expressed in embryonic stem cells and during development, particularly in the neural lineage. They promote DNA demethylation to regulate gene expression. Dysregulation or mutations of Tet enzymes have been linked to human craniofacial and neurodevelopmental disorders and many cancers. This proposal studies how various enzymatic activities of Tets regulate neural stem cell biology. Findings will broaden our knowledge of the epigenetic regulation of neural stem cells and nervous system development. This will have implications in identifying therapeutic targets for treatment of neurodevelopmental disorders as well as enhancing applications of neural stem cells for clinical use.